Genetic and epigenomic determinants of hearing loss in Hispanic populations

ABSTRACT [originally submitted with R01DC019642 and included here with minimal modifications]:
Sensorineural hearing loss (SNHL) is a leading cause of disability and affects ~1.4 billion people globally,
including different age groups and ethnicities. Although around 150 genes have been identified for SNHL, the
Hispanic population remains understudied for SNHL, with most Hispanic studies focused on a single gene GJB2.
A few countries studied – Chile, Mexico/Hispanic-American, the Philippines – have a low prevalence of GJB2
variants, suggesting that SNHL cohorts from these countries have novel genes or variants for discovery.
Additionally, Hispanic children are at risk for environmental exposures to chemicals that may lead to epigenetic
modifications and cause SNHL. Our overarching hypothesis is that SNHL has a unique, population-specific
allelic and epigenetic spectrum in Hispanic-descent populations. We assembled an international group of
researchers with complementary expertise in otology, genetics, epigenomics and functional genomics, with
previous collaborative experience that signals this project will be highly productive. In our previous studies, we
identified novel variants in Hispanic-American and Filipino patients with SNHL, including genetic variants that
were associated with temporal bone anomalies and predictive of cochlear implant outcomes. We have in place
efficient pipelines for the identification of novel SNHL genes in families and differentially methylated regions
(DMRs) in case-control cohorts, as well as validation methods in animal models and epithelial cells. Our goal is
to determine genetic and epigenetic risk factors in Hispanic children with SNHL. For Aim 1, we will identify
SNHL variants from next-generation sequence data using a tiered approach, which includes Sanger sequencing,
filtering, homozygosity mapping, linkage analysis and transmission disequilibrium tests. We will recruit 500
Hispanic families, including large families sufficient for genome-wide significant linkage, and submit DNA
samples to sequencing and analyses. Novel SNHL genes and variants identified in these families will be followed
up with protein localization and hearing studies in mouse and zebrafish models, and mutation constructs in
epithelial cells. For Aim 2, we will perform an epigenome-wide association study by profiling the methylome of a
well-powered cohort of 500 SNHL probands and 500 hearing children matched by age, sex and population, in
order to identify DMRs that are associated with SNHL. For the top identified DMRs, we will utilize CRISPR-dCas9
technology on epithelial cells to determine if targeting the methylation site will affect gene expression. Integration
of methylation profiles and genetic data using methylation quantitative trait locus analysis will aid in
understanding genetic vs. environmental contributions to SNHL. Overall, this project will impact genetic
screening protocols and genetic counseling particularly in Hispanic populations, as well as improve
understanding of the hearing mechanism and lead to new targets for the development of treatment of SNHL.
For this two-year diversity supplement, work will focus on Aim 1 and the beginning of Aim 2.

Public health relevance
PROJECT NARRATIVE This Project Narrative was originally submitted with R01DC019642 submission system requirements. and is included here unchanged to satisfy Hearing including analytic gene loss is a leading cause of disability in the United States and worldwide, affecting billions of people, individuals across age groups and those of Hispanic background. By using genomic technologies and techniques, this project will identify genetic variants as well as regions of the human genome that change expression and function and cause hearing loss in Hispanic children.Results of this study will aid not only in the identification of causes of hearing loss and genetic counseling of families with hearing loss, but also in understanding the basic functions of the human ear and the discovery of new therapies for hearing loss.